Environmental risk factors linked to TDP-43 proteinopathies

ABSTRACT
Most neurodegenerative diseases are sporadic with unknown etiology that likely stems from the interaction
between genetics and the environment, the latter of which continues to remain poorly understood.
Epidemiological studies have linked environmental exposures to the development of TDP-43 pathology, widely
considered a hallmark of frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS) but has now
been expanded to a host of other age-related neurodegenerative disorders including Alzheimer's disease (AD)
(collectively referred to as TDP-43 proteinopathies). To begin addressing some of the major gaps in our
understanding of how environmental risk factors are linked to neurodegeneration, we performed a high-content
microscopy screen to identify environmental toxicants that mediate TDP-43 dysfunction and identified
pathology “promoters” that have never been linked to TDP-43 or dementia, thus opening the possibility that we
can 1) uncover new risk factors that impact the onset or progression of neurodegeneration, 2) identify the
cellular pathways and disease contexts through which they operate, and 3) provide a new paradigm for
therapeutic interventions that are based on environmental susceptibility. We assembled a team of experts
covering TDP-43 pathogenesis, genetic modeling, high-content screening, and computational modeling to
address our overarching hypothesis that distinct classes of at-risk environmental toxicants drive TDP-
43 dysfunction, neurodegeneration, and memory & motor decline. To address this hypothesis, we will
evaluate a high priority subset of environmental toxicants identified in our screen based on their prevalence
and levels of human exposure. In Aim-1, we will examine the pathophysiological relevance of toxicant
exposure using in vivo and neuronal models that allow us to interrogate their functional impact. In Aim-2, we
will evaluate exactly how toxicants mediate TDP-43 dysfunction and will examine direct cysteine-dependent
and indirect stress-responsive mechanisms that would link environmental toxicants to enhanced TDP-43
aggregation. In Aim-3, we will evaluate the extent to which toxicants affect TDP-43-dependent pathways vs.
global disruption of other key FTD/ALS-associated signaling pathways. This study is innovative because it is
the first systematic survey of at-risk chemicals affecting TDP-43, enabling us for the first time to connect
environmental agents to neurodegenerative disease. Our study is also significant because it could radically
transform our understanding of how an environmental agent may drive or perhaps increase susceptibility to
disease, which could logically inform strategies to alleviate or mitigate disease burden.

Public health relevance
PROJECT NARRATIVE The environmental contribution to neurodegenerative diseases has been suggested from epidemiological studies, however, a comprehensive understanding of environmental agents that increase disease susceptibility remains a major unresolved question in the field. A toxicant screen coupled to high-content imaging has identified a set of environmental agents as putative triggers that drive TDP-43 dysfunction, a hallmark of neurodegeneration. This study will shed light on the identity, mode of action, perturbed signaling pathways, and the pathophysiological impact of these factors, with major implications towards disease prevention and mitigation strategies that alleviate cognitive and/or motor decline.